EFFECT OF ENDOTOXIN ADMINISTRATION ON CYP2E1 ACTIVITY IN NORMAL HEALTHY SUBJECTS

To evaluate the effect of LPS on specific P450 isoforms via the use of in vivo probes (chlorzoxazone) in human volunteers.